THIS CONTRACT IS TO PROVIDE MEETING SUPPORT FOR THE NATIONAL EYE INSTITUTES (NEI)/OFFICE OF THE DIRECTOR (OD).

Workshop support including: Retinal Challenge Competition: Technical Planning Meeting To Develop Retinal Organoids for use in 1) Disease modeling, 2) Drug Development, and 3) Transplantation